Facilitation as a Strategy for Implementing the Novel TBI-RECOVER Intervention into Substance Use Treatment: A Mixed Methods Hybrid Type 2 Effectiveness-Implementation Feasibility Trial

PROJECT SUMMARY
Approximately 60% of clients who enter substance use disorder (SUD) treatment have had at least one lifetime
exposure to traumatic brain injury (TBI). TBI of any severity can result in chronic cognitive and behavioral
impairments that, if unaddressed, can undermine the effectiveness of SUD treatment and lead to early
treatment termination. The Ohio State University TBI Identification Method is a well-established, validated
method for identifying clients with TBI, and neurocognitive accommodations can be used to overcome
impairments and optimize client treatment success. However, our preliminary research demonstrates that
neither TBI screening nor neurocognitive accommodations have been adopted in outpatient SUD treatment
settings due to inadequate provider knowledge and skills to implement these interventions, as well as poor
implementation readiness and support. External facilitation is an implementation strategy that can address
these barriers to increase the adoption, reach, implementation, and sustainment of these interventions, but few
studies have evaluated facilitation on intervention uptake in outpatient SUD treatment. Guided by Reach,
Effectiveness, Adoption, Implementation, and Maintenance (RE-AIM) and Exploration, Preparation,
Implementation, and Sustainment (EPIS) frameworks, I will conduct an embedded mixed methods hybrid type
2 effectiveness-implementation feasibility trial to: [Aim 1] Evaluate facilitation as a strategy for increasing the
adoption, reach, implementation, and maintenance of the TBI-RECOVER intervention model (i.e., OSU TBI-ID,
symptom screen, and neurocognitive accommodation) in outpatient SUD treatment; [Aim 2] Examine the
feasibility and preliminary effectiveness of the TBI-RECOVER intervention model compared to treatment as
usual on clients’ treatment self-efficacy, substance use severity, and treatment retention; and [Aim 3] Assess
client satisfaction and provider acceptability of TBI-RECOVER, and utility of the facilitation strategy for
implementation of TBI-RECOVER. The following training objectives will support these research aims and my
career goals: (1) Gain advanced training in dissemination and implementation science, specifically in hybrid
effectiveness-implementation trials, and implementation strategy development and evaluation; (2) Acquire
training in substance use treatment research for adults with comorbid SUDs and TBI; and (3) Advance my
career independence through conceptualizing and leading implementation trial research, R01 grant writing,
and leading research teams. This proposal is directly aligned with NIDA’s 2022 – 2026 strategic plan to
investigate novel treatment interventions and enhance optimal implementation outcomes in real-world
treatment contexts. This NIDA K01 will provide me with the necessary resources to advance and maximize my
skills to launch an independent, NIH-funded career and situate me as a leader in implementation science, TBI,
and substance use treatment research. The results and training gained through this K01 will inform a fully
powered hybrid effectiveness-implementation trial to scale-out TBI-RECOVER using facilitation.

Public health relevance
PROJECT NARRATIVE Traumatic brain injury (TBI) is a common condition among adults entering substance use disorder (SUD) treatment that can result in neurocognitive impairments which undermine treatment effectiveness if left unidentified and unaddressed. Validated TBI screening methods and neurocognitive accommodations are existing interventions with potential to improve treatment outcomes, but these interventions are rarely adopted, implemented, or sustained in SUD treatment organizations. This mixed methods hybrid type 2 effectiveness- implementation feasibility trial will simultaneously evaluate external facilitation as an implementation strategy for increasing the adoption, reach, implementation, and maintenance of the TBI-RECOVER clinical intervention model (i.e., TBI and symptom screening, and neurocognitive accommodations), and investigate the preliminary effectiveness of TBI-RECOVER on clients’ treatment self-efficacy, substance use severity, and treatment retention.